Linking Epigenetic-Therapy Induction of Inflammasome Signaling to Generation of a BRCAness Phenotype

Abstract
PARP inhibitor (PARPi) resistance remains a clinical hurdle, with therapy limited to breast and ovarian cancer
(OC) patients with BRCA mutations, and some activity seen in OC patients with intact BRCA. Our preclinical
studies demonstrate that combining a hypomethylating agent (DNMT inhibitor) and the novel PARPi talazoparib
inhibited tumor growth regardless of BRCA mutation status in both breast and OC by inducing inflammasome
signaling that generates a BRCAness phenotype, synergistically causing cancer cell death. This led to a dose-
finding phase I clinical trial in TNBC funded by Pfizer and Astex and we propose a phase II trial combining a
DNMTi and PARPi in breast and OC patients with intact BRCA that includes correlative analyses in serial patient
samples and mechanistic studies in vitro and in vivo using immunocompetent mice treated with DNMTi-PARPi
combination therapy. The overall goal of this proposal is to expand the benefit of PARPi therapy to a much
larger group of patients and further dissect mechanisms of PARPi cytotoxicity and resistance. Our central
hypothesis is epigenetic therapy-inducing inflammasome signaling generates BRCAness that enhances the
efficacy of PARPi in BRCA-proficient TNBC and OC. We propose three aims. Aim 1: To test the hypothesis
that combining DNMTi + PARPi generates STING-dependent IFN and inflammasome signaling leading to
a BRCAness phenotype that increases anti-tumor immunity in the tumor microenvironment. We
hypothesize that DNMTi + PARPi activates STING and inflammasome signaling leading to BRCAness in BRCA-
proficient TNBC and OC. We will conduct mechanistic studies of factors linking immune signaling to BRCAness
phenotype, functional analysis of immune subsets in immune-competent mice treated with PARPi-DNMTi
combination. Aim 2: To test the hypothesis that DNMTi in combination with PARPi activate reactive
oxygen species (ROS)-mediated DNA damage leading to cell death in BRCA-proficient TNBC and OC.
We will investigate how ROS generated by DNMTi-PARPi combination enhances DNA damage response (DDR)
signaling, induces STING activation and enhances immune responses against TNBC and OC tumors using
immune-competent mice. Aim 3: To assess the clinical activity of DNMTi-PARPi combination in TNBC and
OC patients in phase I/II clinical trials. After completing the ongoing phase 1, we propose a phase II study in
two patient cohorts (one TNBC, one OC), serial tumor biopsies and circulating correlatives to test mechanistic
hypotheses derived from our preclinical studies in patient samples. We will probe modulation of BRCAness-
HRD, DDR genes, ROS signaling, immune signaling genes and functional analysis of immune subsets. Impact:
Combining DNMTi-PARPi to induce a novel link between STING-mediated immune signaling and direct induction
of a BRCAness-HRD phenotype represents a potentially important treatment advance and therapeutic option for
women diagnosed with TNBC and OC who lack BRCA mutations and for which there is an urgent clinical need.
Efficacy may be further enhanced by including immune checkpoint therapy to this treatment strategy.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will directly test a novel epigenetic therapy and PARPi combination in the clinic. Associated correlatives and basic laboratory studies will reveal critical molecular insights into the mechanisms underlying synergy and resistance in BRCA-proficient breast and ovary cancer. Ultimately these findings will develop new treatment strategies with associated biomarkers for cancers with critical clinical need. Therefore, the proposed research is relevant to the NCI’s mission of supporting cancer research to advance scientific knowledge and help all people live longer, healthier lives.